GHESKIO Clinical Trials Unit

PROJECT ABSTRACT: GHESKIO is a Haitian organization dedicated to research, service, and training in
HIV/AIDS with a 37 year track record of NIH-funded clinical research. GHESKIO has two clinical sites in Port
au Prince, Haiti. The Downtown site has large HIV/TB clinics, a maternal child health center, a cardiovascular
center, and programs in adjacent slums. The North site has HIV/TB clinics, an MDR-TB hospital, and a BSL3
TB laboratory. The GHESKIO Clinical Trials Unit (CTU) has two clinical research sites (CRSs) enrolling male
and female participants across the lifespan, including pregnant women, infants, children, adolescents and
adults. The GHESKIO CTU will continue to participate in two networks: Adult HIV/AIDS Therapeutic Trials
(ACTG) and Maternal, Adolescent, Pediatric therapeutics (IMPAACT). We propose the following three aims:
1. Operate a single organization (GHESKIO) CTU with two research sites that is integrated, cohesive,
and able to respond rapidly to a breadth of emerging research priorities. The CTU will maximize
efficiency by having a single research component for administration, communication, evaluation, community
liaison, data management, regulatory assurance, quality management, and training program. Each CRS has its
own pharmacy. The main laboratory is at GHESKIO-North and the downtown site has a satellite laboratory.
2. Conduct adult HIV/AIDS therapeutic trials at GHESKIO-Downtown and GHESKIO-North - ACTG: Haiti
has the highest HIV prevalence in the hemisphere with 2.0% of adults HIV infected. Both GHESKIO sites
(Downtown, North) have large HIV-infected adult ART naïve and ART-experienced cohorts available for
recruitment into trials. Haiti also has the highest rates of TB with a prevalence of 1,066/100,000 in Port au
Prince. GHESKIO treats ~ 2,000 TB patients annually including patients with MDR-TB who are available for
enrollment into TB treatment trials. GHESKIO has established a new cardiovascular disease research unit to
study the chronic complications of HIV.
3. Conduct maternal, adolescent, and pediatric HIV/AIDS trials at GHESKIO-Downtown- IMPAACT:
GHESKIO-Downtown has the expertise, research capacity, and populations for trials of new antiretroviral drugs
in children, adolescents and pregnant women. GHESKIO pediatricians identify and enroll HIV-infected
newborns for trials of intensive therapy to induce an ART free remission. GHESKIO investigators are leaders in
PK studies of TB drugs in children and pregnant women. We will be leading a trial evaluating one month
isoniazid/rifapentine prophylaxis in pregnant women. GHESKIO will introduce studies on nutritional
interventions in pregnant women and newborns to improve their growth and neurologic development.

Public health relevance
Project Narrative: GHESKIO is a Haitian organization dedicated to research, service, and training in HIV/AIDS with a 37 year track record of NIH-funded clinical research. The GHESKIO Clinical Trials Unit has two clinical research sites in Port au Prince and will conduct research in two NIAID networks: The adult HIV/AIDS therapeutic clinical trials group and the maternal-adolescent-pediatric HIV/AIDS trials group. The goal is to improve the treatment of HIV, tuberculosis, and HIV complications across the lifespan in pregnant women, adolescents, children, and adults of all ages in Haiti and around the world.